TO5. CLINICAL COORDINATING CENTER FOR NIDA'S CLINICAL TRIALS NETWORK. CONTRACT TYPE: IDIQ TASK ORDER. POP: 8/15/24 - 8/14/29

This contract supports work that is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.